Tools for probing the physical paralipidome of membrane proteins

Project Summary
Membrane (MPs) proteins constitute ~30% of the mammalian proteome and 60% of all drug targets. In
mammals, these MPs are solvated by hundreds of distinct lipid types, which can vary dramatically between
organelles, across the membrane bilayer, and laterally within a bilayer. Importantly, lipids not only host MPs,
but also control their function. Lipids can regulate MP function both as cofactors and ligands, but also through
the biophysical properties that arise from lipid collective behaviors. Such properties include fluidity, tension, lipid
packing, bilayer thickness, and lateral domains. Further, MPs can selectively recruit local lipid environments
that are distinct from the bulk membrane, with varying preferences for lipid types and structural properties (e.g.
thickness). These conformation-specific local membrane environments, recently termed paralipidomes, have
been reported in isolated and simulated systems, but never directly measured in cells. This proposal intends to
overcome this technology gap by covalently modifying MPs with membrane-sensitive fluorophores with the goal
of developing and characterizing probes for local MP nano-environments and demonstrating their capabilities
in living cell membranes. Cell membrane biophysics relies largely on synthetic fluorescent reporters whose
photophysical properties are sensitive to their local membrane environment, e.g. Laurdan, Flipper-TR, and
NileRed. While these have been used extensively, in many cases it remains unclear which membrane properties
such probes actually sense. In Aim 1, we will employ a combined simulation-experiment methodology to
calibrate various sensors to specific membrane structural parameters. We will determine the spatial range
sensed by various linker designs and evaluate whether these sensors are affected by coupling to MPs. In Aim
2, we will take a two-pronged approach to demonstrate proof-of-concept for applications of these probes to
measuring membrane nano-environments in cells. We will measure how MP paralipidomes evolve through the
secretory pathway by coupling sensors to proteins whose transit through the secretory pathway can be tightly
controlled. Next, we will measure how the transbilayer asymmetry of lipid distributions in living cell membranes
produced local biophysical asymmetries around MPs. We aim to show that MP-coupled reporters can probe the
properties of individual leaflets and use these to evaluate biophysical asymmetries at the plasma membrane
and in internal organelles. Completion of these aims will provide proof-of-concept for a straightforward,
validated, transferrable experimental toolbox for probing local membrane environments around various MPs.
Application of these tools will allow access to fundamental open questions about how MPs assemble their local
membrane environments and how they can be regulated by their functional paralipidomes.

Public health relevance
Project Narrative (Public Health Relevance) Membranes proteins in mammalian cells are surrounded by a complex array of lipids with unique structural consequences. While the properties of bulk membranes have been extensively studied, the local properties around membrane proteins have not been measured in living cells. This proposal aims to address this technology gap by developing sensors that will reveal the properties and functions of the local lipid environments around membrane proteins.